Investigating the role of protein-acyltransferase zDHHC5 in T cell antitumor immunity

PROJECT SUMMARY/ABSTRACT:
Investigating the role of protein-acyltransferase zDHHC5 in T cell antitumor immunity
The potential for long-lasting, protective antitumor immunity has become feasible with cutting-edge cancer
treatments such as Immune Checkpoint Blockade (ICB), adoptive cell transfer therapies, and cancer vaccines.
Despite an increasing number of patients meeting the eligibility criteria for these treatments, a significant portion
does not experience any benefits, ushering in the era of combination therapy. Examination of tumor
microenvironments through high-throughput sequencing and various in vivo models has uncovered distinct
transcriptional states, epigenetic modifications, proteomic variances, and metabolic profiles distinguishing
responders from non-responders to immunotherapies. These findings underscore the critical importance of
comprehending the molecular mechanisms underlying these observed differences, particularly the
circumstances in which interferon-producing and interferon-stimulated antigen-specific cytotoxic T cells prove
effective in eliminating tumors.
We propose that the protein acyltransferase, zDHHC5, plays a key role in regulating the kinetics of STAT1
signaling, thereby influencing the response of T cells to local interferon signaling. The biochemical examination
of palmitoylated STAT1 reveals a dependence on the expression of zDHHC5, with interferon gamma inducing
this palmitoylation. Our bioinformatic analysis indicates an upregulation of zDHHC5 in early activated T cells, a
finding confirmed by assessing protein levels in activated mouse and human T cells. Furthermore, T cells from
melanoma patients treated with anti-PD1 (pembrolizumab) and exhibiting no tumor recurrence display
significantly higher zDHHC5 transcripts compared to those from patients experiencing recurrence. In our initial
murine tumor model, T cell-conditional zDHHC5 knockout mice demonstrate the essential role of zDHHC5 in T
cell-dependent antitumor immunity, as immunogenic MC38 tumors exhibit significantly accelerated growth in
these mice. We seek to characterize the molecular mechanism of STAT1 palmitoylation at the subcellular,
cellular, and organismal levels. Furthermore, we plan to test the translational impact of zDHHC5 by modulating
its expression in preclinical murine models of immunotherapy.

Public health relevance
PROJECT NARRATIVE Palmitoylation, an under-studied post-translational modification, imparts phase-changing properties to proteins, affecting their localization, stability, and signaling, and we have found novel evidence that it may regulate IFN signaling in T cells. Given the crucial role of IFN signaling in anti-tumor T cell responses and cancer immunotherapy, and the challenges in modulating this signaling within T cells, this proposal aims to comprehensively investigate how zDHHC5, a critical palmitoyl-acyltransferase (PAT) expressed in T cells, impacts T cell-mediated anti-tumor immunity through IFN signaling. Our research will explore zDHHC5's potential to enhance cancer immunotherapy by regulating IFN signaling and examine its broader transcriptomic effects.